ANALYSIS OF TRENDS IN AND RISK FACTORS FOR PERMANENT TOOTH LOSS

The objectives of this study are to characterize the trends in tooth loss in the U. S. population and major sociodemographic using data from repeated cross-sectional surveys and to model risk factors for tooth loss using longitudinal data from panel studies.